DEVELOPMENT AND POLARITY MODULE

This subproject is one of many research subprojects utilizing the resources provided by a Center grant funded by NIH/NCRR. The subproject and investigator (PI) may have received primary funding from another NIH source, and thus could be represented in other CRISP entries. The institution listed is for the Center, which is not necessarily the institution for the investigator. Recently, with the appearance of our more advanced methodologies and general interest in understanding the physiological mechanisms behind development and polarity, the BRC has seen an increasing demand from the developmental biology community. For this reason, and because of the importance of the field, a research module in Development and Polarity was formed. The coordinator is Ken Robinson of Purdue University whose research interest lie in the field of tip growth and left-right asymmetry. Overall the modular goal has been defined as: "Furthering the understanding of the physical mechanisms by which developmental polarities are created and maintained, both during embryonic development, repair and regeneration."